Clinical and translational studies of RUNX1 and FPDMM

Germline mutations in RUNX1 cause familial platelet disorder with associated myeloid malignancies (FPDMM), a rare autosomal dominant disease. Patients with this disorder have defective megakaryocytic development, low platelet count and defective platelet functions that lead to clotting defects, and predisposition of the patients for hematological malignancies. FPDMM patients have a life-long risk of hematopoietic malignancies, with variable clinical presentation and disease penetrance among families with different RUNX1 germline mutations, and even between affected individuals within a single family who have the same RUNX1 mutation. Currently there are no good biomarkers or easy assays to predict disease outcome, and the patients need to have annual office visits and invasive procedures such as bone marrow biopsy to monitor their disease progression. The fact that many FPD patients do not develop leukemia suggest that RUNX1 mutation by itself is not sufficient for leukemogenesis; additional somatic mutations followed by clonal evolution are needed. Several studies suggest that somatic mutations in the normal RUNX1 allele could be one of the second hits. In addition, ASXL1, CBL, CDC25C, FLT3, PHF6, SRSF2 and WT1 have been identified as recurrently mutated genes. However, most of these studies were based on relatively small patient cohorts and the findings do not always agree with each other. Most importantly, it is not clear if any of these mutated genes play roles in leukemia development. To address these issues for better understanding of the clinical course and underlying pathogenic mechanism of FPDMM, we launched a natural history study of FPDMM at the NIH Clinical Center in early 2019. https://clinicaltrials.gov/ct2/show/NCT03854318 https://clinicalstudies.info.nih.gov/ProtocolDetails.aspx?A_19-HG-0059.html%20InternalRUNX1 The goals of the natural history study are to identify and follow patients with FPDMM with the hope of identifying biomarkers that can predict which patients will progress and develop malignancies and to identify secondary gene mutations that may impact clinical presentation, disease severity, and progression to malignancies. Through our study we hope to determine genotype-phenotype correlations for RUNX1 mutations and validate the importance of 2nd hits that cooperate with RUNX1 germline mutations for leukemogenesis. And we desire to comprehensively phenotype the patients to determine the full spectrum of the manifestations of the germline RUNX1 mutations. We started to enroll patients in July 2019 and so far, a total of 198 individuals (98 patients) from 55 unrelated families have been enrolled. Enrolled patients have been invited to visit NIH CC yearly for comprehensive checkups, and so far 60 of the patients have visited NIH CC at least one time. They typically spend 1-3 days at the NIH, with extensive phenotyping at the Clinical Center, including bone marrow aspiration/biopsy as well as other clinical & research labs, procedures, imaging, and subspecialty consultations when needed. We collect peripheral blood and bone marrow samples for hematological tests as well as genomic sequencing tests. We focus our attentions on documenting clinical manifestations associated with FPDMM, including those outside of the hematopoietic system. As expected, almost all patients have reduced platelets and/or morphological/functional defects of platelet. Some patients have abnormalities affecting other blood lineages as well. Many patients have eczema and/or allergies, and others have GI problems. We are still accumulating and analyzing data to determine if any of these non-hematopoietic findings are related to RUNX1 mutations. Targeted panel sequencing, whole exome sequencing, RNA-seq, and SNP-array have been performed with bone marrow and peripheral blood samples from the patients to detect secondary mutations and clonal hematopoiesis, as well as to characterize disease progression. We plan to prospectively sequence blood and bone marrow samples obtained yearly from these FPDMM patients and correlate the findings with clinical observations. We are also using model systems, both cell culture models and animal models, to perform functional and translational studies based on our findings in the patients.